The reninness score: integrative analysis of multi-omic data to define renin cell identity

ABSTRACT
Renin cells are crucial for survival. They are well-known for their function in blood pressure regulation, fluid-
electrolyte homeostasis, kidney development, and tissue morphogenesis. In the fetal kidney, renin cells are
progenitors for multiple cell types that retain epigenetic memory of the renin phenotype in adults. When
homeostatic threats arise, the descendants of renin progenitor cells can transform to re-express the renin
phenotype to restore homeostasis. But the mechanisms of this process, known as "recruitment," have yet to be
discovered. Furthermore, the regulatory networks that control the identity, fate, and recruitment of renin-
expressing cells are unknown. This work comprehensively explores the open chromatin landscape of renin-
expressing cells, defines the regulatory factors and transcription factor networks that determine renin cell identity
and govern the recruitment process, and develops a novel computational method to score "reninness" based on
epigenetic signals.
The rarity of renin cells and the complexity of this phenotype-switching process presents a challenge of
distinguishing renin-expressing cells from other kidney cells. This work will address this challenge by integrating
ATAC-seq data and RNA-seq data from renin-expressing cells and a wide variety of other cell types. This
proposal offers an extensive perspective of the epigenetic landscape of renin-expressing cells and regulatory
element changes in the renin recruitment by performing analyses of differentially accessible genomic regions
with computational approaches. In addition, it proposes a method to score samples along a "spectrum of
reninness" with given ATAC-seq data. The outcome will aid in overcoming the challenge to identify the rare renin-
expressing cells among other kidney cells. This proposal also uses computational approaches to define the
transcription factor networks that governs renin recruitment which provides opportunities for follow-up research
to verify and potentially fill the gap in understanding the cell-fate switching process mechanisms.
Newly defining open chromatin regions and transcription factor networks will improve the scientific understanding
of the epigenetic landscape of renin-expressing cells and the mechanisms controlling the identity, fate, and
recruitment of renin cells. This proposal has the potential to uncover potential therapeutic targets for alternative
treatment for kidney diseases, vascular diseases, and hypertension. The proposed novel computational method
to score the "reninness" from ATAC-seq data will be useful in identifying renin cells in signal-cell data, measuring
the level of response of kidney cells under homeostatic threats, predicting renin-related disease progression,
and evaluating the effectiveness of treatment for the renin-related disease.

Public health relevance
PROJECT NARRATIVE The goal of this project is to develop a computational tool to quantify and study the chromatin configuration and transcriptional regulators characteristic of renin-expressing cells and renin recruitment process. By studying the regulatory networks of renin recruitment, the proposed project will investigate potential therapeutic targets and novel ways to diagnose and monitor treatment progression for kidney diseases, vascular diseases, and hypertension.